FAMILIES WITH GENETIC SUSCEPTIBILITY TO BREAST CANCER

BRCA 1 is a putative tumor suppressor gene located on chromosome 17q21, conferring an 85% lifetime risk of developing breast and/or ovarian cancer on women carrying BRCA1 germline mutations. The isolation of BRCA1 will likely provide insight into the biology of breast cancer as well as lead to predictive testing for genetic susceptibility to breast cancer. Immortalized lymphocytes from families with apparent autosomal dominant transmission of breast cancer are essential reagents in our efforts to identify BRCA1.